Investigating sex differences in DDX3X mouse models

Abstract
De novo mutations in the RNA binding protein DDX3X result in DDX3X syndrome. DDX3X
mutations are also associated with autism spectrum disorder (ASD) and may account for 1-3% of
unexplained developmental delay (DD) in females. Yet, our understanding of DDX3X function in
the developing brain is limited. Our funded grant aims to understand the mechanisms by which
DDX3X loss of function and missense mutations perturb cellular function. This supplement will
focus on sexually dimorphic phenotypes linked to DDX3X. Most de novo mutations are in DDX3X
females though increasing numbers of cases in males have been observed. We have discovered
that complete loss of Ddx3x in females causes striking microcephaly. In contrast, complete
knockout in males phenocopies haploinsufficiency in females. Our data suggest that these
differences between males and females may be due to altered expression of the paralog, Ddx3y.
In this supplement, we will test the hypothesis that phenotypic differences in males and females
associated with Ddx3x loss are due to compensation by the paralog, Ddx3y. To test this, we will
use single cell transcriptomics to quantify cell composition and transcriptome changes associated
with Ddx3x loss in males and female embryonic brains. Additionally, we will use knockdown and
rescue experiments to test the functional redundancy of Ddx3y and Ddx3x for embryonic brain
development. These experiments will give valuable new insights to understand roles for Ddx3x in
neurogenesis at a cellular and molecular level. Importantly, this proposal is designed to give
fundamental experimental training in mouse genetics, embryology, sequencing, histology and
microscopy. This supplement also includes a comprehensive mentoring plan for career
development.

Public health relevance
This project will advance our understanding of how mutations in the RNA binding protein DDX3X disrupt its function and result in neurodevelopmental disease across different sexes. It will further an understanding of the etiology of neurodevelopmental disorders, including intellectual disability, microcephaly, and autism. Therefore, this study may eventually help in the development of diagnostic and therapeutic options for broad neurological disorders.